The role of adoptive cellular therapy on myeloid-derived suppressor cell depletion in glioma

Project Summary/Abstract
Malignant brain tumors are the leading cause of cancer-related death in children and a significant cause morbidity
and mortality in adults. Despite aggressive treatment, outcomes remain dismal and limited by a highly
immunosuppressive tumor microenvironment which includes myeloid-derived suppressor cells (MDSCs). A
promising therapeutic alternative developed by our group is called adoptive cellular therapy (ACT) which includes
myeloablative host conditioning accomplished using total body irradiation (TBI), hematopoietic stem cell rescue,
tumor-specific T cell transfer, and dendritic cell vaccine. ACT demonstrated significant improvements in overall
survival across multiple brain cancer models, leading to pivotal approvals by the FDA for several investigational
new drug applications. Our group has observed that ACT dramatically alters the glioma microenvironment.
Hematopoietic stem cells migrate to the glioma microenvironment and differentiate to dendritic cells, which
displace host-derived myeloid-derived suppressor cells. Additionally, hematopoietic stem cells secrete CCL3,
promoting T cell infiltration into the glioma microenvironment. These observations suggest that the glioma
microenvironment is radically altered after ACT and that other mechanisms may influence the cellular milieu
underlying ACT’s efficacy. It is the goal of this proposal to elucidate the impact of ACT as it related to overcoming
glioma immunosuppression and specifically the MDSC niche. Our preliminary data support our notions that ACT
dramatically impacts the MDSC niche in glioma: (1) ACT mediated intratumoral depletion of MDSCs and reduced
their proliferative capacity, (2) ACT promoted accumulation of MDSCs in secondary lymphoid organs, (3)
repopulation of the glioma microenvironment with MSDCs was abrogated by ACT, (4) myeloproliferative
chemokines were significantly reduced in the glioma microenvironment following ACT. Given these premises,
two aims have been proposed to study this novel relationship in glioma. Aim 1 will identify the mechanisms
governing MDSC depletion in ACT. To achieve this, flow cytometry-based assays will quantify cell apoptosis and
cell death in addition to innovative use of gold nanorods and computed tomography to translationally measure
cell migration in vivo. This aim is supplemented by multiplex analysis of cytokines and chemokines found in the
glioma microenvironment to sustain future efforts in identifying the specific soluble molecules governing MDSC
migration. Aim 2 will assess the impact of brain irradiation on MDSC accumulation and ACT efficacy. Following
a survival study, we will leverage geo-spatial genomics approaches in conjunction with our gold nanorod imaging
modality to track cells. This work is significant because depletion of immunosuppressive MDSCs represents a
significant barrier to efficacious immunotherapy development. This project is innovative because it will utilize
gold nanorods (GNRs) to elucidate in vivo migration of MDSCs in ACT-treated mice. These translational findings
will optimize host conditioning protocols to maximize antitumor immune responses, limit iatrogenic toxicity, and
reveal cellular mechanisms of overcoming cancer-driven immunosuppression.

Public health relevance
Project Narrative Brain cancer is the leading cause of cancer-related death in children. Our preliminary data suggest that adoptive cellular therapy may overcome a challenging treatment barrier known as cancer-driven immunosuppression through its inhibition of myeloid-derived suppressor cells. This proposal will assess the impact of adoptive cellular therapy on immunosuppressive cell mechanisms and how brain irradiation can optimize adoptive cellular therapy, limit iatrogenic morbidities, and ultimately improve long-term quality of life and outcomes for patients affected by malignant disease.